Cold Spring Harbor Laboratory Course on Proteomics

Abstract
CSHL Proteomics Course
The proposed Cold Spring Harbor Laboratory Course on Proteomics is to be held each
summer from 2018 through 2022. Proteomics is one of the pillar technologies of systems biology by
which hundreds or thousands of proteins can be monitored and characterized simultaneously. In
combination with genomics and metabolomics approaches, proteomics is an enabling core
technology to probe biological activities in parallel, providing unprecedented analytical power into
diverse biological processes in mammalian development and disease. Models of many human
diseases have been developed in a wide variety of animal systems, in particular vertebrate models
such as mouse, zebrafish, rat and frog, and invertebrate models such as worms and flies; and
increasingly the use of new stem cell technologies is being harnessed to produce powerful in vitro
models to be deployed alongside animal models. There is a growing need for implementation of
systems biology approaches to these models, which necessitates an in-depth understanding of the
challenges and pitfalls of various “high-throughput” technologies, achieved in part by hands-on and
highly focused training.
This intensive two week laboratory and lecture course will focus on cutting-edge proteomics
approaches and technologies. Students will gain practical experience purifying and identifying protein
complexes and enriching/characterizing post-translationally modified peptides using the latest
methods. In the protein profiling portion of the course, students will gain hands-on experience in
quantitative proteome analysis methods: they will be taught label-free and covalent isotopic-labeling
approaches to differentially profile changes in proteomes. Students will be trained in high-sensitivity,
microcapillary high pressure liquid chromatography (nanoHPLC) coupled with nanospray-ESI and
tandem mass spectrometry. Both single dimension and multidimensional separation methods coupled
to mass spectrometry will be taught. In the targeted proteomics section of the course, students will be
taught to analyze and process shotgun proteomics data in order to accurately identify and quantify
selected proteins: they will be trained to select and design transitions for targeted peptides and to
setup and perform SRM/MRM mass spectrometry assays. They will learn to process and interpret the
acquired data to measure and validate changing quantities of targeted proteins in a variety of
biological samples. For all sections of the course, a strong emphasis will be placed on data analysis.
Outside lecturers will discuss proteomics topics and methods not directly covered in the course
including de novo sequence analysis; 2D-gel fractionations and detecting/quantifying protein-level
changes using DIGE; advanced mass spectrometry methods; statistics; the analysis of intact
proteins, and native mass spectrometry; and functional proteomics.
The overall aim of the course is to provide each student with the fundamental knowledge and
hands-on experience necessary to be able to perform proteomics experiments and properly analyze
the resulting data. The long term goal is to train students to identify new opportunities and
applications for proteomics approaches in their biological research and to learn how to integrate these
into systems biology and model organism approaches to human biology and health.

Public health relevance
NARRATIVE Systems biology experiments provide new, revolutionary insights into biological processes improving our understanding of their regulations and thus, laying the fundation for the development of new medical methods and technology. Proteomics represents a suit of methods that yield information about the qualitative and quantitative changes in proteins upon physiological changes, in disease or as a result of treatment. The Cold Spring Harbor Laboratory Proteomics Course `jump starts' researchers in this complex field by providing hands-on training in experimental methods, thorough exercises in data analysis and tutorials on the latest technical developments. Thus, the course enables the participants to immediately apply advanced proteomics technologies in their own research. In addition, it provides an opportunity to network with research peers, and to learn the challenges and pitfalls through hands-on access to the latest available equipment. .